NIGMS Equipment Supplement for R01GM146385 TSGC

Summary
The stress hormone, cortisol, coordinates the body’s chronic metabolism, but also coordinates acute responses to stress by
regulating stem cell differentiation in different tissues, restraining inflammatory and immune responses from
being hyperactive, and coordinates acute metabolic responses to nutrient composition and feeding or fasting. Cortisol
is also known as a glucocorticoid because it controls glucose metabolism. Synthetic glucocorticoids (GCs) are wide
used for reducing pain and inflammation across many diseases, but can cause insulin resistance, muscle atrophy, and
osteoporosis. We have developed an approach to studying GCs that enables us to understand how the glucocorticoid
receptor coordinates these activities by binding to specific genes and changing the proteins made by those genes to
control tissue-selective activity. This occurs as the GCs bind to the receptor and change its shape, enabling it to interact
with different enzymes that control transcription. Previous efforts to understand these processes have been hampered by
the fact that most of the existing GCs that we study are very similar. We instead make GCs that have a full range of
desirable and undesirable activities, which gives us the statistical variance to understand them, a technique we call ligand
class analysis, as we identify different classes of GC ligands that interact with different transcriptional regulatory enzymes
to control expression of specific genes. Another major barrier has been the very wide expertise needed to understand the
links between the GC chemical structure, receptor structure, the interacting coregulators, the regulated genes, and the
tissue selective activities. We have assembled the required expertise and approaches to overcome these barriers by
studying GC action on skeletal muscle, stem cell differentiation into bone, inflammation, and immune responses to
colitis. We will use a chemical systems biology approach with novel GCs along with an integrative structural biology
platform to define the signaling code for the glucocorticoid receptor in these aims: Aim 1 Biology: Identify which
GC effects are correlated and which can be separated using physiologically relevant biology for the study of
skeletal muscle, T cell differentiation, inflammation, and colitis, and osteoblast mineralization and effects on bone.
Aim 2 Chemistry: Development of GCs to perturb GR structure and function in novel ways. We will enlarge three classes
of compounds based on specific structural hypotheses to enlarge the chemical-structural space and test a novel steroidal
scaffold to access new chemical space. Chemistry will focus on creating a diversity of effects on bone versus skeletal
muscle while maintaining anti-inflammatory effects of the compounds. Aim 3 Structure: identify the structural
underpinnings of selective GC signaling. We will apply machine learning and regression approaches to our structural and
biological data to build and test models defining the mechanisms drive tissue-selectivity and identify which processes
are globally coordinated to control differentiation and stress responses at an organismal level. Understanding
the structural and molecular mechanisms of selective modulation will lead to breakthrough understandings of allostery and
the development of improved GCs for medicine.

Public health relevance
Project Narrative Glucocorticoids regulate genetic programs in all tissues to control inflammation, metabolism, and differentiation as a primary stress response hormone, but synthetic glucocorticoids can achieve tissue- selective effects through unknown mechanisms. The goal of this project is to understand how differences in the chemical structure of the synthetic glucocorticoids alters the shape of the receptor to differentially control stress responses across tissues, and in doing so develop glucocorticoids for treatment of colitis with improved skeletomuscular on target side-effects